Yale Center for Genome Analysis Shared Resource

YALE CENTER FOR GENOME ANALYSIS SHARED RESOURCE - PROJECT SUMMARY/ABSTRACT
The Yale Center for Genome Analysis (YCGA) was established in 2010 to provide next-generation sequencing
(NGS), single-cell genomics, spatial multiomics, microarray and bioinformatics support for YCC members. The
Center is a full-service facility dedicated to providing multiple genomic analyses using state-of-the-art
technologies. The services provided by YCGA to YCC include DNA and RNA isolation; sample processing for
sequencing and microarray, epigenetics tool kits, single cell multiomics and spatial multiomics analyses, primary
and downstream bioinformatics data analysis, collaborative development of new genomic technologies with
YCC investigators, provide methods and other write-ups for grants. Additionally, the staff has obtained
equipment and Center grants to maintain a technological cutting-edge and reduce the cost of sequencing.
During the most recent funding period, a total of 374 principal investigators utilized services provided by YCGA,
of which one hundred twenty-five of these users (33%) were YCC members. The majority of this use came from
Genomics, Genetics and Epigenetics (GGE) and Cancer Immunology (CI) Research Programs.
YCGA provides free consultation and training for YCC members. The Shared Resource is led by Director
Shrikant Mane, PhD, Professor of Genetics, whose experience is complemented by the strong expertise of Guilin
Wang, PhD, and Bony Dee Kumar, PhD.
The Specific Aims of YCGA are to provide: 1) NGS services using multiple sequencing platforms, including
Illumina, Oxford Nanopore (Nanopore) and Pacific Biosciences; 2) Single cell genomics using the 10X Genomics
and Mission Bio platforms; 3) Single cell spatial transcriptomic analyses using 10x Visium, Curio seeker,
NanoString CosMx, 10x Xenium and MERFISH (Multiplexed Error Robust In-Situ Hybridization); 4) Genotyping
and methylation analyses using Affymetrix and Illumina microarray platforms; 5) Research and development.
YCGA continuously carries out biotechnology research to develop improved methodologies and tools to test the
relative merits of new technologies and to generate preliminary results for NIH grants. 6) Bioinformatics.
Francesc Lopez, PhD, and Zhao support the secondary analysis needs of YCC members. Their salary is
supported (50%) by YCC. (6) Consultation. YCGA makes every effort to develop collaborative relationships with
its users and takes interest in their scientific projects. 7) Education and training. Staff members actively
participate in YCC Grand Rounds, departmental seminars, and YSM Dean’s workshops aimed at providing
principles and technical details of the various genomic technologies.

Public health relevance
YALE CENTER FOR GENOME ANALYSIS SHARED RESOURCE – NARRATIVE Not applicable.